Administrative Core

Project Summary – Administrative Core (Core A)
The Administrative Core will support all aspects of the Center’s research, training/career enhancement, and
outreach missions. In terms of the Center’s collaborative research (Aim 1), Core A will provide the
organizational structure for meetings of Center personnel, advisory boards and other researchers. The Core
will also foster collaboration among Center investigators and other researchers in the Parkinson’s disease (PD)
research community at Emory University and within the Udall Center network. The Core will administer the
Center’s internally funded pilot grant program for PD research at Emory University. Further, the Core will
provide fiscal and regulatory oversight, will prepare and submit progress reports to NIH and facilitate resource
sharing by handling external requests for non-clinical Center research resources and materials. The
administrative Core will also oversee the Center’s extensive education and training activities for students,
postdoctoral fellows, clinical residents and fellows, and junior faculty members (Aim 2). Besides helping with
the organizational aspects of laboratory-based training, the Core will organize a quarterly PD research seminar
series as well as other recurring educational sessions. Core A will closely interact with partners at Emory to
optimize career enhancement options for trainees and will provide one-on-one grant-writing mentoring for
investigators generating proposals concerning PD research. Finally, in conjunction with a Community Outreach
Board, the Core will plan and implement the Center’s active outreach program (Aim 3). Outreach activities will
include lectures at PD support group meetings and other public teaching sessions, as well as an annual
outreach event which will be organized in a small-group format, allowing patients and caregivers to learn about
ongoing PD research within the Udall Center and across the Emory campus. Many of these outreach activities
will utilize partnerships with local and national PD organizations. Serving all three aims, the Core will maintain
the Center’s website. The Core’s activities will benefit greatly from existing University attributes and resources,
such as the University’s traditional focus on basal ganglia research, with multiple ‘systems’ oriented
researchers on campus, the presence of very active undergraduate and graduate training programs in
Neuroscience and related fields, a robust slate of academic services for postdoctoral fellows, and the presence
of one of the largest movement disorder programs in the US. The Core’s three aims will also be strongly
supported by internal financial contributions, generously contributed by several stakeholders at Emory
University, in recognition of the importance of the Center’s contributions.